Discovery of Addiction-Related Genes with Advanced Mouse Resources

PROJECT SUMMARY/ABSTRACT
Our overarching goal is to discover the genetic and genomic mechanisms underlying behavioral predisposition
and development of addiction. Addiction remains a substantial worldwide social and economic burden despite
extensive efforts to curb drug availability and use. The high heritability of cocaine addiction, indicates that the
propensity to develop a substance use disorder (SUD) after drug exposure is genetically influenced. Both
human and animal studies indicate that behavioral traits such as novelty seeking are strongly correlated with
the propensity to develop an SUD, but the biological basis of this relationship is unknown. We identify and
characterize biological mechanisms of addiction and predisposing behavior by harnessing advances in mouse
genetic resources, including the high-precision Diversity Outbred (DO) mouse population, validation in
genetically modified mice, gene expression quantitation through RNA sequence analysis, and computational
and statistical methods in systems genetics. In Aim 1 we will identify genetic mechanisms underlying
predisposing novelty-related traits and drug self-administration through quantitative trait locus (QTL) analysis in
a large set of DO mice. The most compelling and tractable of these will be validated in gene targeted mouse
models. The intravenous drug-self administration (IVSA) paradigm, considered the gold standard for the
assessment of addiction traits in rodent research, will enable quantification of the core features of addiction
including initiation of drug use, poor extinction and enhanced reinstatement of reinforced drug taking. In Aim 2
we will quantify gene expression genetic variation in two connected addiction relevant tissues, the prefrontal
cortex and striatum, map expression QTLs and identify genetic correlates of predisposing behavior using RNA-
seq in a drug-naïve subset of DO mice, and disseminate these results through widely used informatics
resources. Gene expression analysis in drug-naïve mice enables separation of the biological substrates of
predisposition to addiction from the biological sequelae of drug exposure. In Aim 3, we will address the
fundamental problem of evaluating coordinated gene expression across multiple components of the addiction
circuitry to assess relative dysregulation toward the identification of global- vs brain region-specific factors in
addiction vulnerability. This will be accomplished through the development of robust multivariate statistical
methods for identification of relations across multiple high dimensional data sets. This strategy will make
continued use of a common collection of phenotypes to relate disparate and incompatible measures across
two independent sets of mice, while extending into multiple tissue co-expression networks. Development of this
technique in the context of addiction research will extend a unifying data integration framework to
multidimensional to human and mouse genetic and genomic studies for all disease areas. Synergy among the
aims will reveal networks from polymorphism to addiction-related behavior.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Drug addiction, a chronic disease driven by neurobiological mechanisms and associated with predisposing behaviors including novelty-seeking and risk-taking, represents a tremendous legal, social, and public health burden both in the US and worldwide. There are limited treatment options and no pharmaceuticals for cocaine use disorder. By using and extending advanced mouse genetics resources and analysis techniques, we will discover biological mechanisms of addiction and related behaviors, which may ultimately result in novel predictive and therapeutic avenues for disorders of addiction.